Rhythm Experience and Africana Culture Trial (REACT)

Abstract
African Americans are almost two times more likely than whites (i.e., Caucasians) to experience Alzheimer's
disease or other dementias. For those over the age of 65, the prevalence of cognitive impairment is 8.8% in whites
and 23.9% in African Americans. Even in the age range of 55-64, African Americans are 4 times more likely to
experience cognitive impairment than their age-matched white counterparts. Increased risk of dementia among
African Americans may be attributed to lower levels and quality of education, lower socioeconomic status (SES),
and higher prevalence of vascular diseases, Type II diabetes, hypertension, and obesity, all of which are
recognized as risk factors for dementia. A critical public health question emerges from these statistics that we
intend to address in this proposal: Is there an effective method for reducing or eliminating the race disparities
in cognitive and brain health? Fortunately, physical activity (PA) interventions may be effective at improving
neurocognitive function and reducing risk for dementia. Despite these promising results, prior PA interventions
have had few African Americans making it difficult to stratify results by race to determine whether African
Americans respond to PA in a similar manner and magnitude as whites. In addition, the terms `physical activity'
and `exercise' are often considered unpleasant, painful, and fatiguing, which can negatively influence interest,
enrollment, and long-term adherence. Methods that increase PA without using the term PA (e.g., dancing) could
be effective at improving health outcomes while simultaneously having a wider impact on translation and long-
term adherence. Here we propose an innovative and culturally sensitive method of increasing PA in older (60-
80 yrs) African Americans. We propose a randomized intervention where 180 older African Americans are
assigned to either a moderate intensity African Dance group 3 days per week (N=90) or to an African
Education group 3 days per week (N=90) for 6-months. Both before and at the completion of the intervention,
we will collect a comprehensive neuropsychological battery and MRI metrics of brain health and function to
identify biological pathways by which PA influences neurocognitive health in an African American population.
This proposal has the potential to utilize community-based activities to improve health of older African
Americans. In addition, it could establish a platform (i.e., dance) to implement future interventions targeting
minority populations to reduce health disparities. We have three primary aims: Aim 1. Examine whether a 6-
month African Dance intervention improves cognitive performance compared to an educational control group.
Aim 2. Examine whether African Dance influences brain morphology, task-evoked neural responses, cerebral
blood flow, and resting state connectivity. Aim 3. Explore potential physiological and socioemotional
mechanisms of the dance intervention. We will collect measures of physical and psychosocial health such as waist
circumference, blood pressure, blood glucose and lipid levels, mood, anxiety, depression, and loneliness and
examine whether intervention-related changes to these measures mediate improvements in cognitive
performance.

Public health relevance
Narrative In this randomized clinical trial, we will examine the effects of African Dance and Africana Education on cognitive and brain function in older African Americans. We will be collecting a battery of cognitive, neuroimaging, psychosocial, physical function measures, and blood-based biomarkers to examine the outcomes and mechanisms of the intervention.